Role of Protein S-Palmitoylation in TGFbeta Signaling and Fibrotic Lung Disease

PROJECT SUMMARY / ABSTRACT
Idiopathic pulmonary fibrosis (IPF) is a highly fatal disease characterized by irreversible destruction of lung
tissue and a median survival well below 5 years. The pathologic effector cells in IPF are collagen-secreting
fibroblasts driven by transforming growth factor beta (TGF-β). Despite the promise of TGF-β inhibition as a
treatment for pulmonary fibrosis, global blockade has been associated with severe side effects, necessitating
the identification of strategic therapeutic targets within this pathway. Harnessing the candidate's formal training
in biochemistry and innovative expertise in protein post-translational modifications, proteomics, and machine
learning, a previously unknown site of lipid modification (S-palmitoylation) on the TGF-β receptor (TGFβR1)
has been discovered that appears to regulate its activity. Additionally, evidence of global S-palmitoyl
perturbation in IPF has been identified. Based on preliminary data, the candidate hypothesizes that S-
palmitoylation of the TGFβR1 receptor represents a reversible pro-fibrotic regulatory mechanism, whose
enzymatic regulators may represent novel anti-fibrotic targets. The proposal’s three aims interrogate the roles
of S-palmitoylation at three distinct levels: molecular, cellular, and regulatory. Aim 1 utilizes cultured fibroblasts
to probe the molecular implications of S-palmitoylation on ligand-induced TGFβR1 phosphorylation and
immediate effectors such as Smads, MAP and Src kinase. Aim 2 uses adeno-associated viral (AAV)-based
fibroblast expression of TGFβR1 to examine the role(s) of S-palmitoylation within two distinct fibrotic mouse
models. Finally, Aim 3 utilizes AAV-based CRISPR deletion to investigate the fibrotic contributions of two
enzymatic S-palmitoyl regulators – palmitoyl transferase Dhhc20 and depalmitoylase Abhd17a – that are
selectively induced in pathologic fibroblasts and may represent novel antifibrotic targets. These aims allow for
the candidate's skill development in cell biology and animal models, while simultaneously supporting a career
development plan that fosters expertise in AAV tools, quantitative microscopy, flow cytometry, mouse handling,
and advanced bioinformatics. The proposed aims and training plan will delineate the role(s) of S-palmitoylation
in IPF and potentially generate a novel therapeutic angle to target pathologic fibroblast signaling and reduce
fibrosis. The mentorship team, led by Dr. Purushothama Rao Tata, includes experts in lung biology, fibrosis,
TGF-β signaling, and proteomics, ensuring comprehensive training and guidance throughout the award period.
This K08 award will pave the road toward the candidate's overarching career goal of anti-fibrotic discovery by
focusing on fibrosis-oriented post-translational protein modifications, ultimately aiming to improve outcomes for
patients with IPF and other fibrotic lung diseases.

Public health relevance
PROJECT NARRATIVE Idiopathic pulmonary fibrosis (IPF) is a devastating lung disease with limited treatments and short survival time. This proposal aims to uncover new mechanisms involving protein lipid attachments (S-palmitoylation) that contribute to IPF progression. By revealing these modifications and their regulators, this research could lead to the development of more efficacious IPF treatments, potentially improving the lung function and survival of patients suffering from this severe disease.